Centrosome Regulation in Development and Dysregulation in Disease

Loss of function studies have identified a large number of proteins critical for the function of centrosomes. The loss of many of these proteins results in the loss of centrosomes from the cell, precluding analysis of other roles they might play beyond centrosome duplication or maintenance. Here we investigate roles for Asl beyond its well-established function in centriole duplication. We take advantage of Drosophila zygotic mutant animals that build centrioles in early development using maternally provided Asl. We then identify these centrioles in larval and adult tissues where they now reside in an environment genetically null for Asl. These remnant centrioles have proven to be a critical tool to investigate Asl, but similar analysis can be performed on remnant centrioles generated using zygotic mutants of other centriole duplication factors. The most striking finding was that the absence of Asl resulted in the massive (up to 30-fold) elongation of centrioles in both germline and somatic cells. Although long, these centrioles maintain normal radial distribution for all the tested proteins, and a characteristic distal centriole tip. In several cell types we found that these long asl mutant centrioles are formed in a manner that results in an extended proximal centriole end such that it spans the entire centriole. However, remnant centrioles in asl mutant hub cells do not grow long. We find this result quite revealing, as it supports the model that centriole elongation requires cells to be actively proceeding through the cell cycle. Our data suggest that Asls role in controlling centriole length is most important in highly proliferative cells where a given centriole has the highest chance of being maintained in the same cell over multiple cell cycles. This is a circumstance common to stem cells. Thus, our identification of significant length control defects in two distinct stem cells suggests that length control by this mechanism might be especially critical in stem cells. Direct protein binding and genetic analysis revealed that Cep97 functions downstream of Asl to exert a significant portion of its centriole length control. The ability of centriole targeted Cep97 to partially compensate for the loss of Asl is consistent with this model. Our data also suggests that Asl does not function exclusively through Cep97, since the long centrioles in cep97 mutants are shorter than those in similarly aged asl mutants. An interesting question raised by our findings is why cells have evolved a mechanism to control centriole length. One possibility is that evolution of the centriole has selected for a minimum centriole functional-unit that can efficiently accomplish its task, in this case serving as an MTOC. Any unessential centriole length might require additional cellular resources, which could provide selective pressure to evolve a centriole length control mechanism. We also identified a role for Asl in sperm basal body function. In the absence of Asl in developing spermatids, we found significant defects in the attachment of the basal body to the nucleus as well as in the assembly and / or maintenance of the flagellar axoneme. Our initial hypothesis was that these defects were a result of the longer, proximalized asl mutant centrioles, but our data proved otherwise. We believe these defects uncover a unique and independent role for Asl during the final stages of sperm development. Asl is associated with the outer surface of basal bodies throughout spermatogenesis and we show it undergoes a dramatic change in localization during the final stages of spermatid development. The scarcity of basal bodies in asl testis makes a detailed understanding of the role of Asl in flagella assembly especially challenging. Future identification of interactions of Asl with proteins involved in flagella assembly and the generation of separation of function mutations in Asl that retain centriole duplication function, but lose basal body functions, will be required to further our understanding of this novel role for Asl. Taken together, we have shown that Asl has roles additional in addition to recruiting Plk4 for centriole duplication. Asl functions to control absolute centriole length, the length of proximal centriole characteristics, and ensures proper basal body functions during spermatogenesis. Insight into additional roles beyond duplication could help shed light on how specific lesions within centriole proteins manifest human diseases.